Cytogenetics Shared Resource

CYTOGENETICS SHARED RESOURCE PROJECT SUMMARY
The central focus of the Cytogenetics Shared Resource (CYT) is to provide high quality cytogenetic and
molecular cytogenetic analysis of human and animal model research samples in a timely, cost-effective
manner for members of the Mayo Clinic Cancer Center (MCCC) and other investigators within the Mayo
research community. External requests are accommodated with discretion. The highly specialized cytogenetic
and molecular cytogenetic services and equipment utilized to provide such services to MCCC users would be
impractical to institute into multiple individual laboratories. These services are ideally provided in a central
location and in a Shared Resource environment, which eliminates the need to duplicate expensive equipment
and technologist training and analysis time. Services within the CYT include: Cell Culture, Routine
Chromosome Analysis, DNA and RNA fluorescence in situ Hybridization (FISH), and Custom DNA Probe
Production as well as RNA FISH Probe Production and a Tyramide Signal Amplification (TSA) protocol.
Together, with the investigator, the CYT assists in determining how these techniques can be utilized to meet
the evolving needs of their research studies. In addition to the test menu described above, the CYT staff also
provides specialized training to investigators for FISH set-up, and microscope use in an effort to minimize
investigator cost and economize technologist time. The staff that makes up the CYT have over 75 years of
combined cytogenetic and molecular cytogenetic expertise. The capability provided by the CYT is not present
in any other Shared Resource facility or research laboratory at Mayo Clinic. The 6 highly qualified and
experienced staff members (3.6 FTE) provide expert consultation in experimental design, troubleshooting,
modification of experiments, and interpretation of results. The staff also serves to help facilitate the translation
of molecular cytogenetic discoveries into clinically available diagnostic assays. In the past grant cycle (2013-
2017), the CYT had a total of 208 users, representing 10 of the 10 MCCC Programs active at the time. Among
our 208 users, 84 (40.4%) are MCCC members. Of these 84 investigators, 57 (68%) have active peer-
reviewed funding. During these past 5 years, the CYT supported the production of 36 peer-reviewed
publications.